Effects of Episodic Food Insecurity on Psychological and Physiological Responses in African American Women with Obesity

Abstract:
Food insecurity, or the lack of sufficient food in both quality and quantity for an active and healthy life, is a
pressing health issue in the United States with over 18% of adults being food insecure. Food insecurity is a risk
factor for multiple chronic diseases, including obesity. Importantly, both food insecurity and obesity are more
prevalent in African American (AA) women compared to other groups. Further, food insecurity is considered a
`cyclic phenomenon' with episodes of food adequacy (i.e., enough food to eat) and food shortage (i.e., not
enough food to eat). More research is needed to better understand why food insecurity is linked to obesity,
including acknowledging the episodic nature of food insecurity as a stressor and identifying underlying
mechanisms. To this end, we will examine the potential role of psychological and physiological parameters in
the food insecurity-obesity linkage and do so in a health disparate population, AA women.
The objective of this exploratory/developmental study is to investigate the episodic nature of food insecurity as
a stressor via responses in body weight and psychological and physiological parameters longitudinally. We will
enroll 30 food insecure and 30 food secure AA women (age 18-65 y) with obesity (BMI 30-50 kg/m2) to
measure 1) daily body weight remotely over 22 weeks and 2) psychological and physiological parameters via
clinic assessments at the beginning and end of 22 weeks. Further, we will assess episodes of food insecurity
and stress on a weekly basis. All participants will be offered ride-sharing as a transportation option to and from
all clinic visits. We hypothesize that food insecure AA women with obesity will demonstrate increased body
weight and changes in psychological and physiological endpoints, whereas food secure AA women with
obesity will not. We will also examine associations between changes in psychological and physiological
parameters and changes in body weight.
Psychological questionnaires will assess stress; executive function, decision-making, and motivation; and
affect and non-homeostatic eating. Physiological measurements will include cortisol, DHEA-S, c-reactive
protein, thyroid hormones, glucose, HbA1c, insulin, and allostatic load. We believe this will be the first study to
examine changes in body weight and psychological and physiological factors in food insecure AA women with
obesity during episodes of food insecurity. Findings from this study will provide a range of novel data that will
be translated into well-powered follow-up grants. This study also has significant public health implications by
addressing the cyclic nature of food insecurity to identify underlying mechanisms that can be targeted to
mitigate the adverse relationship between FI and obesity and reduce health disparities in minority populations.

Public health relevance
Project Narrative: Food insecurity is the lack of enough food for an active and healthy life and is associated with poor health outcomes, such as obesity. This study will investigate the relationship between food insecurity and obesity in African American women by measuring a number of psychological and physiological mechanisms. Results from this study are important so that researchers, clinical practitioners, and public health officials can develop better strategies to address food insecurity and obesity in African American women.